Effects of Genetic ANGPTL3 Deficiency on Hepatic Lipid Regulation and Lipoprotein Production

ABSTRACT. Cardiovascular disease is the leading cause of death worldwide. A major goal of pharmacologic
therapy is to lower plasma lipids, especially low-density lipoprotein cholesterol (LDL), the cardinal risk factor for
coronary artery disease (CAD). Patients with familial hypercholesterolemia (FH) have increased risk of
developing early-onset CAD due to dysfunctional clearance of LDL from circulation and increased plasma levels
of this atherogenic lipoprotein. Underdiagnosis and undertreatment of FH are exacerbated by limited therapeutic
options. However, one strategy has been successful at lowering LDL in FH patients: Inhibition of the hepatically
secreted protein Angiopoietin-like protein 3 (ANGPTL3). A monoclonal antibody (evinacumab) inhibiting
circulating ANGPTL3 recently obtained FDA approval for treatment of FH due to substantial reductions in LDL,
even in patients with complete deficiency of the LDL receptor (LDLR). In contrast, existing lipid-lowering agents
largely rely on LDLR function to remove this atherogenic lipoprotein from the blood. In accordance with the
NHLBI Research Priorities, it is important for researchers to define molecular characteristics that can predict
meaningful or inadequate responses to therapy in different populations with cardiovascular disease. Despite
promising clinical trial data, the LDLR-independent mechanisms by which ANGPTL3 inhibition lowers LDL have
not been fully characterized. This is an important question to address not only to describe how drugs inhibiting
ANGPTL3 work but also to recommend targets for reducing plasma lipids via a novel LDLR-independent pathway
of lipoprotein metabolism. The main hypothesis of this proposal is that ANGPTL3 deficiency lowers LDL in part
by modulating hepatic lipoprotein assembly and lipid metabolism while simultaneously altering characteristics of
secreted VLDL particles. This hypothesis will be addressed by achieving the goals outlined in this proposal. The
proposed experiments employ a combination of hepatocyte cell culture systems, including immortalized cancer
cells and an advanced cell culture model that produces hepatocyte-like cells (HLCs) from induced pluripotent
stem cells (iPSCs). These iPSCs are derived from a unique population of human subjects with complete genetic
ANGPTL3 deficiency. Aim 1 will use these models to test whether changes in lipoprotein secretory transit and/or
lipid metabolism contribute to LDL lowering in ANGPTL3 deficiency. Aim 2 will test whether lipoprotein particle
secretion kinetics, clearance, size, and/or lipid composition could also be contributing to LDL lowering. These
experiments will be carried out as part of a rigorous fellowship training plan in a well-resourced and highly
collaborative environment. Consistent with the NHLBI Strategic Plan, the proposed studies will help future
clinician-investigators and the patients they serve by improving understanding of the functions of ANGPTL3-
inhibiting drugs; describing a role for ANGPTL3 in hepatic lipoprotein metabolism; and potentially recommending
new therapeutic targets for lipid-lowering agents by elucidating an LDLR-independent mechanism for clearance
of circulating LDL.

Public health relevance
PROJECT NARRATIVE High cholesterol is a cardinal risk factor for cardiovascular disease, the leading cause of death worldwide. Inhibition of Angiopoietin-like protein 3 (ANGPTL3) has emerged as a therapeutic target for lowering cholesterol, especially among patients with the underdiagnosed and undertreated condition familial hypercholesterolemia (FH), but this protein’s role in modulating low-density lipoprotein cholesterol (LDL) metabolism is incompletely understood. The proposed studies aim to describe the effects of total ANGPTL3 deficiency on hepatic lipid regulation and lipoprotein assembly, thereby delineating the mechanisms by which drugs inhibiting ANGPTL3 lower LDL independently of the LDL receptor (LDLR).